Mechanical characterization of carotid plaques for stroke risk assessment

Stroke is the fifth leading cause of death and the primary cause of preventable disability and
hospitalization in the U.S according to the most recent statistics by the American Heart
Association. Each year, approximately 795,000 people continue to experience a new or recurrent
stroke. On average, every 40 seconds, someone in the United States has a stroke, and someone
dies of one approximately every 4 minutes. This high fatality rate is partly due to the fact that
state-of-the-art methodologies such as CT, MRI and ultrasound are currently failing to inform
timely intervention. Identification of patients with high-risk, asymptomatic carotid plaques despite
their low stenoses remains thus an elusive but essential step in stroke prevention. In current
clinical practice, the risk assessment of carotid plaque rupture is based on the degree of intima-
media thickness (IMT) and endoluminal stenosis despite the fact that they do not necessarily
correlate with vulnerable plaques or subsequent rupture. Current clinical modalities fall thus short
in informing on plaque stability. Reliable information on plaque stability would ensure timely
treatment, especially in asymptomatic or low endoluminal stenosis patients whose stroke risk
remains severely underdiagnosed. Such information shown to be critical but clinically unavailable
lies in the plaque compliance and the associated blood flow. Lipid plaques (which are typically
less stable and are associated with ischemic stroke) have been shown to have distinct stiffness
from calcified plaques. Increased arterial stiffness has also been reported in stroke patients. The
objective of the proposed study is thus to amplify the role of carotid sonography by optimizing the
combined PWI and VFI methodologies (PWI+VFI) and quantifying the biomarkers of compliance
and flow in order to provide critical biomechanical information on plaque stability. In reported
studies, our group has shown that plaque characterization in large animals and stroke patients
can be achieved. We have demonstrated that PWI+VFI is capable of characterizing carotid
plaques based on their distinct stiffness and flow. In this study, we aim towards the
characterization of carotid plaques for the ultimately reliable assessment of ischemic stroke risk
based on plaque wall and flow biomarkers. We thus hypothesize that PWI can significantly
reinforce the diagnostic capability of a conventional vascular ultrasound. The team assembled is
highly multi-disciplinary encompassing expertise in ultrasound imaging, biomechanics, vascular
radiology, pathology, neurology, vascular surgery and biostatistics. Following the proposed
studies, this highly translational technology could be readily integrated in a standard sonogram to
accurately inform carotid plaque stability and thus subsequent timely treatment.

Public health relevance
This study aims to develop a quantitative imaging technique of vascular stiffness and flow that can be integrated into conventional ultrasound scanners to inform neurologists and neurosurgeons regarding the stability of a detected carotid plaque detected and its propensity for stroke. This new technology may constitute an important tool for accurate carotid plaque staging and thus timely prevention of stroke.